Administrative Core

Administrative Core
The Administrative Core includes the four PIs, Drs. Ahles and Gany (MSKCC) and Drs. Hubbard and
Barabino (CCNY), Research Education Core Leaders Dr. Hricak (MSKCC), with Dr. Hubbard, PCORE
Leaders Dr. Leng (MSKCC), and Dr. Dorn (CCNY), Linguistic and Cultural Responsiveness Shared Resource
Core Leaders Drs. Gany and Diamond (MSKCC) and Drs. Uyar and Riobó (CCNY) and the Administrative
Core staff, from both CCNY and MSKCC. The U54 Administrative Core coordinates all of the Partnership
activities and ensures that the Partnership continues to function effectively and efficiently. Specifically, the
Administrative Core will: 1) coordinate biweekly meetings of Partnership PIs, quarterly meetings of the
Administrative Committee, which includes the leaders of the Research Education Core and Partnership
Community Research and Education Core, and quarterly IAC meetings, as well as the Annual Program
Steering Committee meeting; 2) meet with the Executive Committee on an annual basis to evaluate the
potential synergy between Partnership goals and new institutional initiatives, including recruitment of new
faculty; 3) provide support for both institutions’ research resources and facilities and to provide access to and
awareness of these resources for Partnership investigators, faculty, and students; 4) coordinate with GMap
Region 4 (CDRN) to ensure that Partnership students have access to regional career resources; 5)
coordinate student placements at either CCNY or MSKCC in research laboratories or service-based learning
projects and to provide administrative support for faculty that teach in Partnership courses; 6) provide fiscal
planning and management for all aspects of the Partnership, including the distribution of developmental
funds; and 7) maintain and update a manual of Standard Operating Procedures.